CE24-001, Grants for Injury Control Research Centers (ICRC) - 2024

UNIVERSITY OF IOWA (UI) INJURY PREVENTION RESEARCH CENTER (IPRC) ABSTRACT
Established in 1991, the UI IPRC aims to prevent, control, and optimize recovery from injuries and violence,
especially in rural communities. The UI IPRC has grown to include 70 researchers from 30 departments and
nine Colleges across the UI campus, as well as a wide network of practice partners representing local and
state government, community organizations, and business. Over the next funding cycle, the UI IPRC will
conduct innovative and multidisciplinary research, training and education, and outreach with a focus on
reaching populations disproportionately affected by injury and violence. Our research projects will address
social and structural factors that create inequities in injury and violence prevention among low-income African
American families (Project 1), racial and ethnic minority populations living in rural communities (Project 2), rural
residents with substance use disorders (Project 3), and rural older adults (Project 4).
The UI IPRC will be led by an efficient organizational structure that promotes engagement and communication
across internal and external research and practice partners. A Leadership Team will oversee daily operations,
informed by: (1) an Executive Committee of UI IPRC and campus leaders, (2) eight Research and Practice
Action Teams organized around our topical areas of interest (suicide prevention, adverse childhood experiences,
drug overdose, older adult falls, road safety, trauma care, firearm safety, and intimate partner violence and
sexual violence prevention), and (3) the UI Division of Diversity, Equity, and Inclusion to ensure our activities and
outputs proactively and purposely promote equity in injury and violence prevention. The Leadership Team will
also be informed by two external advisory groups, including the State Injury and Violence Prevention Advisory
Committee comprised of public and private stakeholders working in injury and violence prevention practice.
The overall aims of the UI IPRC are to: Maintain an efficient, effective management structure that supports and
sustains program growth, promotes equitable prevention efforts across populations disproportionately affected
by injury and violence, and integrates academic and practice expertise to translate research into effective
programs and policies (Administrative Core); Promote and advocate for equitable injury and violence prevention
across diverse populations and serve as a trusted information center for partners and the public in the region and
nation (Outreach Core); Provide multidisciplinary, inclusive, and accessible academic and professional training
and education to advance an equitable field of injury and violence prevention (Training and Education Core)
and; Support scientifically rigorous and innovative research through our four Research Projects and competitive
Exploratory Research Project program, which is sponsored annually by $90,000 in institutional commitment. A
primary goal of the UI IPRC over the next funding cycle is to make significant progress toward closing
implementation gaps between injury and violence prevention research and practice in rural populations.

Public health relevance
UNIVERSITY OF IOWA INJURY PREVENTION RESEARCH CENTER PROJECT NARRATIVE The University of Iowa (UI) Injury Prevention Research Center (IPRC) aims to prevent, control, and optimize recovery from injuries and violence, especially in rural communities. The UI IPRC works toward this goal through research, training and education, and outreach, focusing on rural populations and multiple types of injury and violence. The UI IPRC will continue its strong tradition of multidisciplinary, collaborative, and integrated activities that engage diverse areas of expertise and multiple local, state, and national partners.